Combining c-Myc inhibitor and SHetA2 for cervical cancer: A promising low-to-no toxicity therapeutic strategy

Cervical cancer is the deadliest female cancer worldwide due to inadequate screening programs and disparities
based on the healthcare system, income, race, and ethnicity. Patients with advanced and recurrent cervical
cancer have complicated clinical management and are often incurable, which worsens their quality of life.
Therefore, alternative treatment strategies focusing on new investigational agents and drug combinations are
needed to improve cervical cancer patients’ outcomes. Metabolic reprogramming, a key hallmark of cancer that
defines malignant behavior and chemoresistance, is a rational target for these strategies. Cervical cancer
metabolism is targeted by our novel investigational agent, SHetA2, which inhibited cervical cancer xenograft
growth without toxicity in preclinical studies. SHetA2 is currently in a Phase-1 gynecologic cancer clinical trial
that kills cancer cells by binding to three heat shock proteins A (Grp78, hsc70, and mortalin) and releasing their
client proteins. SHetA2 disrupts mitochondrial dynamics and functions in cervical cancer cells, thereby inhibiting
oxidative phosphorylation and metabolic viability. However, these cells responded by upregulating glycolysis as
a resistance mechanism. Inhibition of glycolysis increased SHetA2 sensitivity in cervical cancer cells both in vitro
and in vivo, suggesting significant promise of SHetA2 combination therapy for cervical cancer. Our preliminary
study demonstrated SHetA2-mediated c-Myc upregulation and the synergistic anticancer activity of the
combination of a c-Myc inhibitor (Myci975) and SHetA2 in cervical cancer cells. Therefore, we hypothesized that
Myc inhibitors would enhance the therapeutic efficacy of SHetA2 in cervical cancer without toxicity by
counteracting the c-Myc-associated growth and metabolic pathways. Furthermore, our preliminary data
suggested an important role for mortalin and calpain in SHetA2-mediated c-Myc upregulation; however, the exact
underlying mechanism of c-Myc upregulation by SHetA2 treatment, the relationship between mortalin and c-Myc
stability, calpain activity vs. c-Myc expression, and the functional role of c-Myc in glycolysis upregulation upon
SHetA2 treatment remain unexplored. This study aims to evaluate the clinical applicability and mechanism of
combining SHetA2 with a c-Myc inhibitor for cervical cancer therapy. In Aim 1, we will perform in vitro combination
studies of SHetA2 and c-Myc inhibitors to select a specific Myc inhibitor that demonstrates better synergy without
toxicity with SHetA2 compared to Myci975, if any. Subsequently, the efficacy of the selected drug combination
will be evaluated in cervical cancer PDX animal model. Molecular markers and metabolic regulators of improved
therapeutic responses will also be investigated. In Aim 2, we will investigate whether: a) Mortalin stabilizes c-
Myc through direct/indirect binding, and SHetA2 interrupts this binding; b) SHetA2 mediated reduction in calpain-
1 expression and activity accounts for c-Myc upregulation; and c) c-Myc upregulation contributes to increased
glycolysis upon SHetA2 treatment. Overall, this study is designed to generate preliminary data that could guide
a cervical cancer clinical trial evaluating our novel drug combination to improve the quality of life.

Public health relevance
Although cervical cancer appears to be a highly preventable disease, it remains the most common cause of death in women worldwide, which negatively impacts their quality of life because the majority of patients are still being treated with highly toxic chemotherapeutic regimens owing to the lack of molecular-targeted therapy. Our overall goal is to evaluate the combined efficacy and underlying mechanism of our novel therapeutic drug combinations, SHetA2 and c-Myc inhibitors, which target key players in cancer development and drug resistance, and to generate preclinical data to support future clinical trials. Overall, this proposal is focused on improving the overall outcome of cervical cancer patients by developing new low-to-no-toxic therapeutic options that could also be pertinent for advanced and recurrent cases by targeting cancer-specific signaling pathways accounting for drug resistance.